CLARITHROMYCIN THERAPY OF M AVIUM IN AIDS PATIENTS--ACTG 157

A Phase II safety and efficacy study of Clarithromycin in the treatment of disseminated M. avium complex (MAC) infections patients with AIDS.